ADOPT-ACCUPRIL DECISION ON PHARMACOTHERAPY

Compare efficacy and safety of quinapril, enalapril, atenolol, and verapamil in controlling blood pressure level in patients with uncomplicated mild to moderate hypertension when used as single-agent therapy in a structured titration program.